The Role of Osteopontin-OGDHL Axis in HFPEF

ABSTRACT The goal of this minority supplement is to train and mentor an underrepresented Jamaican young lady during her transition from a medically-trained doctor to a physician scientist. Dr. Williams is an ambitious post-doctoral candidate who performed research via the Health Disparities & Cultural Identities research lab at Florida International University (FIU) assessing HPV risk. She was also a recipient of the South East Alliance for Graduate Education and the Professoriate (SEAGEP) award for undergraduate research in 2010. During this period, she assisted with the development of laboratory protocols for the Biomaterials laboratory at FIU. Dr. Williams was introduced to our team by another current Diversity Supplement awardee (Dr Julian Dunkley). Williams learnt about our NIH-funded HFpEF project and became very interested in training in basic and translation research. If granted, this postdoctoral supplement combined with the excellent environment, support, and extraordinary resources at the Interdisciplinary Stem Cell Institute and the University of Miami Miller School of Medicine will provide Dr. Williams with the tools and methodology necessary to become an independent physician scientist in the field of cardiovascular research where female Jamaican scientists are rare. This proposal is the logical extension of the parent grant entitled “Role of OPN-OGDHL Axis in HFpEF” (1R01HL140468) and is performed within the scope of the original project. As such, we will characterize the blood pressure and heart rhythm in the new HFpEF cardio-renal mouse model we recently characterized by implanting a telemetry device. We will assess the arrhythmia in the Alport mouse ± beta agonist/antagonists. The mice used will be from the three different genetic strains that we developed. This new approach barely modifies the proposed strategy and models, which keeps these additional experiments within the scope of the parent grant. The proposed experiments are anticipated to finish within the next 18 months.

Public health relevance
NARRATIVE Due in part to the complex heterogeneity of the disease phenotypes as well as an absence of mechanistic insights into disease development and progression, clinical trials targeting heart failure with preserved ejection fraction (HFpEF) so far have failed and there is no etiological therapy for HFpEF. The current proposal will allow us to present a new mouse model for HFpEF and understand new mechanisms underlying the development of this syndrome.